T32 Research Training Program in ImmunoEngineering

Abstract
With the burgeoning of the fields of immunology and immunotherapy in the last few decades, the use of
pharmaceutical products, biomedical devices, and biomaterials in immunological research and clinical
applications has rapidly expanded. Accordingly, there has been an increasing need for engineers trained with
the quantitative skills necessary for developing effective immunotherapies and translating these developments
to industry. Immunology is a basic science that has a lot of applications that need to be translated to positively
impact patients' lives. Most companies working in this area of ImmunoEngineering hire basic scientists since
immunology is a basic science, albeit one that has a lot of applications amenable to translation in order to
positively impact patients' lives (e.g. anti-inflammatory or immunosuppressive drugs, avoiding transplant
rejection, adoptive cell therapy for cancer treatment). However, these individuals do not have training in
engineering nor quantitative or systems perspectives. In contrast, engineers are also hired into companies that
work in ImmunoEngineering areas, but often they do not have immunology training. The pre-doctoral training
program described in this application is aimed to better equip engineers by training them in immunology (as
well as in engineering). Funding for four trainees per year is requested for five years. Through this
ImmunoEngineering training program, a new type of engineering doctoral trainee is being developed, one who
can apply engineering principles with knowledge of immunology to make impacts on new treatments for
disease and who will fill a critical gap in existing bioengineers entering today's work force. This training
program will furthermore provide translational medicine and ethics training to equip trainees with important
“soft skills” such as project and time management, ethics and understanding of the translational aspects of
bring a product to market.

Public health relevance
Project Narrative This pre-doctoral student training program will develop ImmunoEngineering leaders of the future with the knowledge and skills in state-of-the-art immunology with application of engineering principles and the leadership skills to take prominent positions in ImmunoEngineering Academia and Industry.